Use of Registries, Claims and Health System Data to Enhance the Evaluation of Cardiovascular Therapies in Clinical Trials

PROJECT SUMMARY/ABSTRACT The timely and efficient evaluation of new medical treatment strategies, therapies and devices is critical to improving public health. Ubiquitous data collected in the routine care of patients, including registries, health systems and payers, remain underutilized sources of information that could be used to support clinical trial evaluations of novel medical interventions, but require validation. Through a collaboration involving the Smith Center for Outcomes Research at Beth Israel Deaconess Medical Center, Harvard Clinical Research Institute, the Harvard T.H. Chan School of Public Health, the American College of Cardiology (ACC), Premier, Inc., Symphony Health Solutions and Medtronic, we will combine data from two landmark clinical trial programs - the Dual Antiplatelet Therapy (DAPT) Study and the US CoreValve Trials - with comprehensive national data from registries, health systems and payers, to test several hypotheses central to the future evaluation of cardiovascular therapies. In Aim 1, we will test the hypothesis that trial outcomes derived from linked registry, hospital, and claims data will be equivalent to outcomes obtained in clinical trials, suggesting that these alternative data sources can, in some cases, replace traditional clinical trial data. In Aim 2, we will test the hypothesis that information collected through registries, hospitals, and claims that was not collected in the original clinical trial, such as prior non-cardiac hospitalizations and markers of frailty, can augment trial data, through improved risk stratification and identification of heterogeneous treatment effects. In Aim 3, we will leverage the linkage of trials with population-based datasets to enable the creation of novel and broadly applicable metrics to assess overall trial generalizability and applicability to understudied subgroups. The linkage of these diverse resources will create an important opportunity to formally evaluate the strengths and limitations of using non-clinical trial data sources to support and improve clinical trial assessments of medical therapies. The information learned has the potential to greatly inform the future conduct of pragmatic and naturalistic clinical trials, while offering novel insights into the efficacy and safety of therapies to treat coronary and valvular heart disease.

Public health relevance
PROJECT NARRATIVE Large amounts of data are collected each day in the routine course of clinical care by health quality organizations, hospitals and insurers. The goals of this proposal are to evaluate whether these data can, first, be used in place of data collected in expensive clinical trials to study the effectiveness and safety of medical therapies; second, contribute additional information to clinical trials to identify patients who benefit the most from treatment; and third, be used to assess whether trials include typical patients similar to those seen in the community. The results of the research will determine how best these data sources can be used to improve our present and future understanding of new medical treatments.